Global Health Reciprocal Innovations SWG

Project Summary/Abstract
Global Health Reciprocal Innovation Scientific Working Group (GHRI SWG)
Global health reciprocal innovation (GHRI) is a recently coined term to describe a new framework for
bidirectional, iterative exchange of technology, methodology, and/or processes between low and middle-income
countries (LMICs) and higher-income countries to address shared health challenges. The UAB CFAR has an
energized and growing number of researchers who are poised to become leaders in the use of GHRI to tackle
challenges in the field of HIV because of (a) UAB’s longstanding partnerships in LMICs, (b) the stark and
persistent disparities in HIV in the U.S. Deep South, and (c) shared characteristics of the HIV epidemics in LMICs
and the U.S. Deep South. The GHRI Scientific Working Group (SWG), led by two NIH-funded UAB faculty who
have experience translating HIV innovations between LMICs and the U.S. Deep South, will catalyze new HIV
research at UAB that uses GHRI, by implementing three specific aims. The SWG will create a new scientific
platform (Aim 1) for scientific exchange and training in GHRI. Networking opportunities (Aim 2) will be created to
link researchers working on similar challenges in HIV in different geographical areas and increase engagement
in GHRI. Finally, the SWG will catalyze and support novel HIV-related projects (Aim 3), working in conjunction
with other global health-oriented cores and centers at UAB to support bidirectional teams to obtain pilot funding
and provide tailored consultation and training around extramural grant opportunities that can support HIV-related
projects that feature GHRI. SWG members will include both UAB researchers, as well as HIV
researchers/implementers at a range of local (U.S. Deep South) and global partner institutions, whose
involvement will be strongly valued.